Kupewa: Optimizing strategies to implement provider recommendation of HPV vaccination for adolescent girls and young women with HIV in Malawi

Project Summary/Abstract
Human papillomavirus (HPV) vaccination is a critical cancer control intervention, particularly in resource-
constrained health systems with limited access to screening and treatment services. Malawi, like many African
countries, has introduced a national HPV vaccine program targeting preadolescent girls – but coverage remains
very low. Clinician recommendation of HPV vaccination is a highly effective evidence-based intervention for
increasing uptake of the vaccine, but there is little information on how to encourage clinicians in low- and middle-
income countries to deliver this recommendation.
The Kupewa project (“prevent” in Chichewa) aims to (A) identify the optimal implementation strategies for
increasing clinician recommendation of HPV vaccination for girls and young women aged 9-24 who are living
with HIV in Malawi; (B) refine this set of optimized strategies by including information about the strategies’
implementability; and (C) ultimately identify the set of strategies that are effective, implementable, and show
sustained effects 18 months after the intervention ends. The study is informed by the Theoretical Domains
Framework and the World Health Organization’s Behavioural and Social Drivers (BeSD) of vaccination
framework.
To our knowledge, this would be among the first applications of intervention optimization alongside
implementation science, and among the first to be conducted in a low-income country. The project will leverage
a robust research partnership between institutions and highly-qualified investigators in Malawi and the U.S., with
engagement of partners from the Malawi Ministry of Health in all phases, from conceptualization to study
execution and results interpretation and dissemination.
Clinician-facing implementation strategies to promote vaccination recommendation in low- and middle-income
countries are understudied but urgently needed to accelerate HPV vaccination programs globally. This study will
provide much-needed insight into ways to promote clinician recommendation of HPV vaccination to the highest-
risk girls and young women in the country with the second-highest burden of cervical cancer globally.

Public health relevance
Public Health Relevance Cervical cancer burden represents a major global health disparity, and women living with HIV are particularly affected. High coverage of HPV vaccine will be necessary to substantially reduce incidence and ultimately achieve cervical cancer elimination in high-burden settings like Eastern Africa; however, uptake of the HPV vaccine in the region is low despite national programs that offer HPV vaccine for free to preadolescent girls. This study will identify optimized implementation strategies – effective, implementable, and sustainable – for increasing clinician recommendation of HPV vaccination for girls and young women living with HIV in Malawi; these findings will have immediate relevance in Malawi, the country with the second-highest cervical cancer burden globally, and for other low-resource settings struggling to achieve high HPV vaccine coverage.